2025 Cannabinoid Function in the CNS Gordon Research Conference and Gordon Research Seminar

Cannabinoid signaling in the CNS is composed of the types 1 and 2 cannabinoid receptors and their cognate exogenous and endogenous ligands. Cannabinoid signaling is widely distributed throughout the CNS and it is implicated in a wide variety of important processes including neurodevelopment, pain, reward, addiction, regulation of stress and homeostasis, learning and memory, motor function, anxiety, and social function. Therefore, understanding the neurobiology of cannabinoid signaling could have broad implications for physiological CNS function and the pathophysiology of neuropsychiatric disorders. The Gordon Research Conference (GRC) on “Cannabinoid Functions in the CNS” and its associated Gordon Research Seminar (GRS) are widely regarded as the best scientific forums in the field of cannabinoid function in the CNS. This GRC meeting has a strong reputation for attracting the most active and renowned scientists in the field and it is an extremely valuable meeting for trainees aiming to become the next generation of cannabinoid neuroscientists. In this application, we request financial support to partially cover expenses for predoctoral, postdoctoral and other trainees to attend the 2025 “Cannabinoid Functions in the CNS” GRS/GRC meetings. The primary aims of this conference are: 1) To provide outstanding scientific programs in the traditions and spirit of the Gordon Research Conferences. The conference will include cutting- edge unpublished data by leaders in the field; a community atmosphere that fosters informal discussion and stimulates new collaborations, and 2) To foster the development of early-career scientists and trainees in the field. For this aim, a GRS will precede the GRC and will focus on increasing professional networks of early-stage scientists, providing a venue for oral scientific presentations for trainees, and career development seminars. A second approach for this aim will be the implementation of a mentoring system during the GRC to increase 1:1 interaction between trainees and senior scientists in the field. The “Cannabinoid Functions in the CNS” GRS/GRC has several unique qualities including a: 1) focus on the CNS, which is not present at any other cannabinoid-centered meeting; 2) strong emphasis on cutting-edge, unpublished data; and 3) continuing commitment to trainees through the organization of the GRS, trainee mentoring program, and career development opportunities. We have incorporated several new scientific topics this year, including reports from ABCD researchers, and will emphasize the results of clinical trials, both successful and unsuccessful.

Public health relevance
The use of cannabis products for therapeutic and recreational purposes is increasing, as is our scientific understanding of the health and neurobiological effects of the endogenous cannabinoid signaling system in the brain. The Cannabinoid Function in the CNS Gordon Research Conference and Seminar is an outstanding scientific meeting where neuroscientists and clinicians studying the effects of cannabinoids can meet to share their unpublished findings, and ideas, and guide the future of scientific research in this field. We request support to assist trainees in the field to attend and present their work in this important and stimulating venue.